Volunteer Scanning on MR

IN FY23 we performed 4 MRIs to test and evaluate the sequences used in support of other research protocols.

In order to optimize the technique and the experimental design of the Brain Biomechanics study, we recruited healthy volunteers under 98-CC-0019 for a series of MRI sessions.

The protocol Estimation of Brain Biomechanics requires the use of MRI elastography (MRE) pulse sequences to obtain data from human volunteers. Commercially available MRE methods do not have the capacity for simultaneously assessing signal from tissues in the brain (from which the signal comes from tissue water) and tissues in the skull (from which the signal comes from tissue lipids). Our collaborators who have developed these sequences had initially developed these sequences for Siemens MRI devices operating at a different field strength and on a different software version from those available to us in the Radiology and Imaging Sciences Department of the Clinical Center.

In doing so, we have established usable methodology for the Brain Biomechanics project.